EPIDEMIOLOGY OF CERVICAL DYSPLASIA IN AMERICAN INDIAN WOMEN

The purpose of this study is to define specific risk factors associated with cervical dysplasia in American Indian women. We specifically aim to use serum cotinine levels to validate self-reported cigarette smoking history obtained by questionnaire.